EVALUATION OF THE AIRWAYS OF NORMAL INDIVIDUALS WITH BRONCHOPULMONARY LAVAGE

The purpose of this project is to obtain biologic materials from the blood and lungs from normal individuals in order to: (1) establish a baseline value for diagnostic tests used to diagnose chronic lung disease; and (2) identify individuals who will be suitable candidates for other protocols such as those involving investigational new drugs.